Unraveling the Mechanisms of Neoantigen Vaccine-Induced Epitope Spreading

Project Abstract
The advent of immunotherapy has reshaped our approach to cancer treatment, with lasting cures achieved in a
subset of patients. Tumor neoantigen vaccines have been shown to effectively prime tumor-directed T cell
responses and induce epitope spreading (ES), a phenomenon linked to improved clinical outcome. ES occurs
when vaccine-induced tumor cell lysis releases additional tumor antigens, which subsequently primes a new
wave of tumor-specific T cells. However, technical challenges have restricted the evaluation of ES to only small
sets of known target antigens, while it remains unknown how T cells primed through vaccines differ
phenotypically from naturally primed (via ES) T cells, and what types of T cell – target cell interactions are favored
with respect to their functional avidities. In addition, ES to novel non-canonical antigens, such as non-canonical
open reading frames (nuORFs), structural variants (SVs), and transposable elements (TEs) may also contribute
to anti-tumor T cell responses when conventional antigens (derived from point mutations and short insertions
and deletions) are scarce. In recent years, the Wu and Schumacher groups have developed a set of
immunogenomics-based tools, which provide new approaches to address these unresolved questions.
Specifically, we have developed neoantigen prediction pipelines facilitating the identification of antigens from
whole-exome sequencing data and mass spectrometry. Further, we have refined our antigen discovery abilities,
by focusing on the detection of potential antigens derived from non-canonical antigens. Finally, we have
conceived HANSolo and PAIR-Scan, novel library-based tools capable of generating functional, paired TCR-
antigen information at scale. With these capabilities, I propose to thus systematically dissect neoantigen vaccine-
induced ES in two distinct settings: In Specific Aim 1, I will systematically evaluate ES in melanoma, a tumor
type characterized by a high tumor mutational burden (TMB). I hypothesize that vaccine-induced ES generates
T cells of memory-like phenotype characterized by a defined spectrum of functional avidities towards their
respective target antigens, resulting in enhanced tumor control. In Specific Aim 2, I will evaluate the
immunogenicity of non-canonical antigens in the setting of high-grade serous ovarian cancer, a tumor with low
TMB, yet rich in nuORFs, SVs, and TE. I will furthermore assess how potential ES to these non-canonical
antigens may contribute to disease control. By relating features underlying ES to clinical biomarkers, I hope to
determine how this phenomenon is related to positive clinical outcomes during cancer immunotherapy.

Public health relevance
Project Narrative Neoantigen vaccines represent an emerging class of immunotherapy, as they can effectively induce and amplify anti-tumor T cell responses. While in the past, the phenomenon of epitope spreading has been linked to improved clinical outcome, it has not yet been studied at scale due to technical challenges. In these studies, I propose to systematically dissect neoantigen vaccine-induced epitope spreading by applying cutting edge immunogenomics tools.